Immunobiology of Myeloid and Lymphoid Cells

This proposal aims to continue to improve the quality and breadth of predoctoral immunology training at
Dartmouth. It builds upon and improves a continually funded T32 program that has been successfully training
the next generation of immunologists for thirty years. The scientific focus is to better understand the immune
system in health and disease and to leverage these findings to develop better therapies for an array of different
conditions where the immune response is central to pathogenesis. Our goal is to provide a cutting-edge program
to train the best graduate students to conduct rigorous and ethical research in the field of immunology. Trainees
will be mentored to become productive researchers who are experts in their fields and also very well-informed
about immunology as whole. Faculty trainers are drawn from a wide variety of areas within immunology. The
program can therefore offer interdisciplinary training that includes the interfaces between immunology and
infectious disease, cancer, mucosal homeostasis, pulmonary disease, autoimmunity and systems biology. In
addition to training in the design, implementation, reproducibility and interpretation of research projects, the
program teaches students how to effectively present their research in seminar presentations and in written
formats such as grant proposals. Major strengths of the program include: (i) the strength of the research
programs of the training faculty. Faculty research program represent a broad array of disciplines within
immunology, many of which span different fields and involve interdisciplinary collaborations with different labs
both within Dartmouth and at other institutions. The relatively small size of Dartmouth laboratories also leads to
very close interactions between faculty and trainees, creating an ideal learning environment. (ii) Students
appointed to the training program enter through two very strong umbrella graduate programs, the Molecular and
Cellular Biology program and the Quantitative Biological Sciences program. Graduate education is coordinated
by the Guarini School of Graduate and Advanced Studies, that offers a wealth of professional development
activities for students, supplemented by activities by training program trainers, to help them with their future
careers. (iii) The Geisel School of Medicine and Thayer School of Engineering at Dartmouth offer state-of-the-
art facilities for laboratory research, computational and statistical resources, an AAALAC approved animal facility
and core facilities for genomics and bioinformatics. In this competitive renewal we detail new training programs
that have been added during the last grant period and new initiatives we propose adding to the training program.
The Dartmouth Immunology Program has had outstanding track record of success in training young
immunologists over the past thirty years, and trainees populate many of the most prominent immunology
laboratories throughout the world. We will augment this success in the current proposal and train scientists who
will become the future of immunology research.

Public health relevance
The goal of this proposal is to continue and improve a program to train the next generation of immunologists and provide them with the tools needed to forge successful careers in research. We recruit the most talented and motivated predoctoral students and our outstanding faculty trainers provide exceptional mentorship and training in how to conduct research in immunology, in addition to preparing them for careers in research and research-related fields. The immune response cuts across all types of disease in the human population, and we are at the beginning of our ability to develop therapies to harness the immune responses for novel therapies, so progress in this field is essential.